THE ROLE OF THE RIBOSOME IN DETERMINING THE FATE OF DAMAGED MRNA

PROJECT SUMMARY The Project Summary is contained within the Research Strategy per NOT-GM-21-030 guidelines.

Public health relevance
PROJECT NARRATIVE Cells employ multiple strategies, including transcriptional and posttranscriptional regulation events, to ensure that the correct protein is made at the right time and place. Failure to do so could result in drastic consequences such as cancer and cell death. This proposal addresses the mechanisms by which protein synthesis is regulated to maintain control over gene expression, which in turn could be used to develop therapeutics aimed at dealing with defects in the translation apparatus.